Proyecto Tariki: Implementation Science for Community-Mobilized Risk Reduction of Dengue

ABSTRACT
There is scientific consensus that there are effective tools and strategies to control dengue, but program
failures are linked to improper implementation. This project brings together researchers with >23 years of
experience in community-based epidemiological dengue research in Iquitos, implementation science, and a
team that successfully developed and implemented a software platform DengueChat, in Nicaragua and
Paraguay, that mobilized communities to control mosquito producing containers in their own homes. Our
project directly addresses past implementation failures by using implementation science theories, models, and
frameworks (INSPIRE, CFIR), dengue epidemiology and entomology expertise, infrastructure and relationships
developed in Iquitos and Lima, and addresses three programmatic gaps identified in Iquitos and incorporates
key lessons learned from the Covid pandemic (differential response to changing risk level), to develop,
implement and evaluate “Proyecto Tariki” – an integrated dengue risk reduction program. Tariki will: (1)
mobilize community members to take control measures in their own homes, (2) enhance surveillance of
disease vectors and febrile case outbreaks, (3) improve triage and management of cases, (4) target and
deploy effective responses during periods of high transmission, (5) promote bi-directional data exchange
between community residents, health care providers and authorities, and other stakeholders, and (6) support
government programs through community engagement and training and implementation on pragmatic
evaluation protocols. We will conduct key-informant interviews and focus group discussions with health and
community stakeholders to understand the system problems and establish a fixed-group of stakeholders called
the ‘Tariki Champions’ (Aim 1). We will also adapt the proven DengueChat application to Iquitos and expand
the platform to include fever surveillance; DengueChat Plus will be the cornerstone of the Tariki program. Tariki
Champions will participate in group model building (GMB) workshops throughout the 5-year project to find
leverage within the system to plan, implement, and monitor and evaluate Tariki using mixed methods based on
RE-AIM metrics focused on epidemiological, entomological, and cost outcomes (Aims 1 and 2). In Year 3, after
reviewing all data using the CFIR domains (including program characteristics, costs, and processes), the
RMOH will take over management of Tariki and scale up program activities across the city of Iquitos (Aim 3),
continuing to monitor the program through RE-AIM metrics and pragmatic evaluations. We hypothesize that
Tariki will reduce risk for dengue by improving community mobilization for control, increasing community
surveillance for febrile illness and case management, and implementing pragmatic protocols for intervention
evaluation.

Public health relevance
PROJECT NARRATIVE Our proposal uses well established implementation science theories, models, and frameworks to develop, implement, and evaluate Proyecto Tariki, a novel dengue prevention and control program. Tariki aims to address 50 years of previous dengue program failures by inclusion of: 1) a proven community mobilization strategy that includes a mobile/web-based application, 2) community led febrile surveillance with direct link to health systems to improve case management, and 3) pragmatic protocols for Ministries of Health to evaluate their vector control interventions. Project adoption, sustainability, and scale-up will reduce transmission risk and health burden of dengue.